Expanding Biomedical Science Training Program Evaluation Capacity through Interactive Modules - Supplement to Initiative for Maximizing Student Development (IMSD) Program

ABSTRACT
Evaluation is an essential component of pre- and postdoctoral biomedical research training
programs including the parent award of this supplement request, the Initiative for Maximizing
Student Development. High-quality evaluation enhances programs by identifying opportunities
for improvement and effectively measuring outcomes. Program personnel often lack
foundational evaluation knowledge, however, and professional evaluators may not be
sufficiently familiar with program nuances, leading to missed evaluation opportunities or unmet
needs. To build evaluation capacity among training program personnel engaged in evaluation,
we propose leveraging existing resources (e.g., eLearning course software), and expertise at
BCM to create five interactive, online modules, suitable for use as an asynchronous, “build-
your-own” short course or for blended instruction. Module one will introduce educational
program evaluation, providing foundational knowledge related to planning; alignment of
outcomes, actions, and assessments; culturally responsive practices; use of findings for
improvement; and generation of evidence to support dissemination and replication. Four
complementary, topic-specific modules will then allow users to develop knowledge most closely
related to their program’s specific evaluation needs (i.e., small sample sizes). After developing
module outlines with an advisory committee of expert evaluators and training program
personnel, the supplement request project director will work with a BCM instructional designer
to build the modules in the eLearning course software, Articulate Rise 360, for which we have
an institutional license. Modules will be piloted with 24 training program volunteers and revised
based on their survey and focus group feedback. Resources from BCM programs will be
gathered and established into an ongoing collection of evaluation materials. Modules and
resources will be available free-of-charge internally and on the external BCM site.

Public health relevance
Project Narrative The parent IMSD (GM056929-24) grant provides research and education experiences for groups underrepresented in biomedical research to attain careers as biomedical scientists in academia and industry. This Supplement proposes to develop five online educational modules on program evaluation methods for use by faculty, staff and trainees participating in the continuum of biomedical research training. The modules will complement existing program evaluation resources, such as the curated website, T32 Program Evaluation Resources, developed at the University of North Carolina at Chapel Hill.